Biological functions of beta herpesvirus encoded non-coding RNAs

Project Abstract: Human cytomegalovirus (HCMV) and Human Herpesvirus 6a (HHV6a) members of the β-herpesvirus family, are pathogens that have evolved to infect a significant majority of the human population. Both viruses retain the capacity to reactivate from latency, which is highly problematic in immunosupressed populations. These two viruses encode numerous factors that undermine host responses to viral infection and alter the subcellular environment thereby promoting efficient viral replication. This proposal seeks to define the biological role for the microRNAs (miRNAs) encoded by these two viruses. We will evaluate the requirement of each miRNA as well as utilize novel and innovative techniques for RNA and protein labeling within viral infected cells. Successful completion of these aims will fill a significant knowledge gap in our understanding of the viral factors that promote pathogenesis.

Public health relevance
Project Narrative: Human cytomegalovirus (HCMV) and Human Herpesvirus 6a (HHV6a) causes significant disease in individuals with weakened immune systems. A novel feature of these viruses is that they encode miRNAs however, the biological requirement and function of these viral factors during infections of cells relevant for in vivo infections remains unknown. In this proposed work we will extend our exciting findings where we have identified specific roles for a HCMV and a HHV6a miRNA to the remaining miRNAs. Characterization of the biological mechanisms controlled by these host factors will provide insight on inhibiting HCMV and/or HHV6a and potentially other viruses in general.